Administrative and Data Management Core

Core A Summary
Core A is an Administrative and Data Management core that will serve all three projects, plus Core B and C, as
well as support the communications and interactions among the investigators and with Columbia Research
Management, the NIH, NIH Program personnel, the Scientific Advisory Board and subaward institution. This
core will provide the vital functions which are essential for keeping this program project organized, synergistic,
productive and compliant. The experienced Administrative and Data Management core staff, under the
direction of Dr. Megan Sykes, will provide program-specific administrative support including: coordinating
interactions between projects and cores, including multiple group meetings each week; organizing regular
quarterly meetings of all the project and core
leaders and personnel; overseeing
expenditures; coordinating communication
with NIAID staff and program personnel; and
organizing the scientific advisory board
meetings.
The second main function of this core is to
provide all of the logistical and technical
support necessary to facilitate expedient flow
of information and secure data storage and
transfer. The successful integration of this
Program Project's leaders, laboratory
personnel and data will depend on an
effective core being the supporting foundation
for all projects and the animal core sites
together.
As provided in the overview section of this application, the illustration of interactions and support is provided in
the embedded image.